Robotic Exoskeleton Gait Training in Transition Aged Persons with Cerebral Palsy

PROJECT SUMMARY/ABSTRACT
Cerebral palsy (CP) results from a perinatal brain injury and is one of the most prevalent and costly
developmental disabilities in the United States. As persons with CP transition from adolescence into adulthood
they continue to be faced with prominent mobility challenges. Despite the increased recognition of the mobility
deteriorations, NIH funding related to transition aged persons with CP is remarkably low. Thus, research focused
on enhancing the mobility of persons with CP during this critical transition period is sorely needed to help narrow
the gap and eliminate this disparity.
Over the last decade, there has been considerable interest in utilizing robotic exoskeletons in a therapeutic
setting for improved mobility. This therapeutic approach is interesting because the exoskeleton can be used
while the patient practices real-world tasks (i.e., stair and obstacle negotiation). However, the current therapeutic
approaches used with these robotic exoskeletons are primarily focused on compensation (i.e., body weight
support, passive leg facilitation), which might dampen motor learning since it can disengage the nervous system.
This proposal opposes this treatment strategy in that we will use the exoskeleton as a treatment tool for
perturbing the legs during locomotion, in order to generate heightened muscular activity and relevant motor
errors in the context of real-world tasks. Our central hypothesis is that the heightened neuromuscular activity
during our exoskeleton gait training will result in clinically relevant gait improvements that will be tightly connected
with beneficial neuroplasticity in the spinal cord and key brain circuits that govern the leg motor actions. The
Specific Aims of this project are: (1) To quantify the degree of mobility changes in transition aged persons (16-
25 years) with CP who undergo our innovative robotic exoskeleton gait training protocol, and (2) To identify
whether transition aged persons with CP who undergo our robotic exoskeleton gait training protocol exhibit
greater neurophysiological alterations in the key brain circuits and spinal cord dynamics that are involved in
planning and executing leg motor actions. In brevity, the experimental design of this project involves transition
aged persons with CP who will undergo 24 physical therapy sessions while wearing a robotic exoskeleton that
will perturb the spatiotemporal gait kinematics during an overground therapeutic gait training protocol. Baseline
and post-therapy measures will include clinical mobility assessments (Functional Gait Assessment, fast-as-
possible 10-meter walk, 1-minute walk, time up and down stairs), magnetoencephalographic (MEG) brain
imaging, and Hoffman reflex (i.e., H-reflex) assessments of the spinal cord interneuron dynamics. Clinical
outcomes will be compared with a cohort of persons with CP that undergo standard gait training without using
the exoskeleton. Beneficial outcomes from this clinical trial will create a new perspective on the use of robotic
exoskeletons as a therapeutic tool for improving the gait of persons with CP.

Public health relevance
PROJECT NARRATIVE Cerebral palsy (CP) is one of the most prevalent and costly developmental disabilities in the United States. Current research and therapeutic interventions related to mobility for transition aged persons with CP is lacking. This project will use clinical mobility outcomes and neurophysiological assessments to probe if a novel robotic exoskeleton gait training protocol will drive beneficial neuroplasticity in transition aged persons with CP.